Conditional Agonism: PD1-Dependent Activation of 4-1BB for Enhanced Safety

PROJECT SUMMARY
Immune checkpoint therapies targeting PD-1, PD-L1, and CTLA-4 have revolutionized cancer treatment over
the past 15 years. Antibody-mediated inhibition of these checkpoints can lead to significant tumor reduction,
durable responses, and prolonged survival. Unfortunately, only 10-20% of cancer patients experience these
therapeutic benefits, and even among responders, relapse remains a challenge. Targeted therapies that activate
co-stimulatory molecules, such as 4-1BB, are being explored to enhance the clinical effectiveness of immune
checkpoint blockade. Several preclinical studies have highlighted the potential of combining anti-PD-1
monoclonal antibodies (mAbs) and 4-1BB agonists, demonstrating robust and durable tumor regression by
activating potent antitumor immunity. However, the initial enthusiasm surrounding these therapies is tempered
by concerns regarding their safety profile, particularly evident in recent phase II clinical trials where first-
generation 4-1BB agonistic mAbs caused severe hepatotoxicity, resulting in two fatalities. Targeting strategies
that confine the co-stimulatory activity to the tumor site is an attractive approach for developing 4-1BB agonists
with improved safety profiles. To this end, we have engineered a bispecific fusion protein, aPD1-4-1BBL,
designed to disrupt PD-1/PD-L1 interaction while harnessing its binding to the PD-1 receptor for localized 4-1BB
hyperclustering. We have developed three murinized (murine-specific) and caninized (canine-specific) aPD1-4-
1BBL constructs with varying biophysical properties to identify the construct with the most optimal combination
of therapeutic efficacy and safety profile. Our preliminary data confirm that all aPD1-4-1BBL constructs induce
PD-1-dependent and FcγR-independent 4-1BB hyperclustering. We hypothesize that the PD-1 blockade and 4-
1BB co-stimulation induced by aPD1-4-1BBL will cause significant tumor regression while avoiding immune-
related hepatotoxicity. Our specific aims will: (Aim 1a) to evaluate the therapeutic efficacy, safety, and toxicity
profiles of murine-specific aPD1-4-1BBL constructs in the syngeneic B16-F0 and B16-F10 mouse melanoma
models and (Aim 1b) to assess the safety and toxicity profiles of canine-specific aPD1-4-1BBL constructs in
healthy beagle dogs. We will employ a cross-species approach to identify an aPD1-4-1BBL construct that
demonstrates superior tumor growth inhibition and has high safety and low toxicity profiles. We will perform
clinical correlative studies on tumor tissues, tumor-draining lymph nodes (TDLNs), and peripheral blood samples
to elucidate the cellular and molecular mechanisms underlying the aPD1-4-1BBL-mediated activation of
antitumor immune responses. Our long-term goal is to utilize the insights gathered from this study to perform
clinical trials in tumor-bearing canine patients using a caninized aPD1-4-1BBL in support of our ultimate goal of
developing an aPD1-4-1BBL construct for human patients that maintains potent antitumor activity without
causing hepatotoxicity.

Public health relevance
PROJECT NARRATIVE Immune checkpoint therapies have provided unprecedented clinical benefits to human cancer patients; however, these benefits are observed in only 10-20% of patients. Novel strategies to enhance the efficacy of immune checkpoint blockade are urgently needed. This proposal aims to evaluate the therapeutic efficacy of a novel PD- 1-dependent 4-1BB agonist using a cross-species approach to determine whether PD-1-mediated 4-1BB hyperclustering can stimulate an effective antitumor immune response while avoiding immune-mediated hepatotoxicity.